AMERSA Annual National Conference

PROJECT SUMMARY/ABSTRACT
The Annual National Conference of the Association for Multidisciplinary Education and Research in Substance
use and Addiction (AMERSA) is the only multidisciplinary meeting for health professional educators and
researchers who teach about alcohol, tobacco, and other drug problems. Founded in 1976, AMERSA’s mission
is to improve health and well-being through interdisciplinary leadership and advocacy in substance use
education, research, clinical care, and policy. In its 45th year, AMERSA remains at the forefront of professional
development through its activities that (1) improve substance use education and clinical practice by promoting
multidisciplinary leadership, mentorship and collaboration; (2) generate and disseminate state-of-the-art
science about substance use research, education and policy; (3) provide an active forum and community for
discussion and debate of health policy topics related to substance use; (4) promote cultural competence and
inclusion among healthcare professionals in their work with persons from underserved and high-risk
populations affected by substance use problems; and (5) build a national network of experts, who will lead
health professional education and research across the substance use spectrum and advise local, national, and
international organizations on evidence-based substance use policy.
Bringing together researchers and health professions educators to learn about scientific advances and
educational innovations, the AMERSA Annual National Conference fosters collaboration within and among
diverse disciplines, backgrounds and professional environments that encourages peer mentoring and career
development. The scientific meeting attracts national and international attendees and provides opportunities
for leadership, collaboration, mentorship, and networking. Cutting-edge plenaries, peer-reviewed abstract
presentations, and skills-based workshops are carefully curated each year to promote the ongoing
development of a critical pipeline of addiction science professionals who teach, study, advocate, and practice
in the field of substance use and addiction. Through these activities, AMERSA has become a professional
home for a thriving academic community of science-driven clinicians, educators, and researchers working
together to prevent and treat substance use disorders.
The proposed 5-year project will strengthen the high quality and diversity of the national meetings, to be held
2022-2026, by (1) providing speaker fees and travel to attract plenary speakers who are preeminent in the
areas of substance use research and education, and (2) providing conference travel award funding and
continuing education credits to increase the participation and career development of persons from nationally
underrepresented groups and disciplines.

Public health relevance
PROJECT NARRATIVE This proposal builds on the considerable strengths of a twenty-year partnership between NIDA and AMERSA to produce an annual addiction science conference that will further open the critical pipeline for a more diverse, equitable, and inclusive community of addiction health professionals and scientists grounded in evidence- based research, practice and policy. AMERSA members represent a wide array of multidisciplinary health professionals, many of whom are national and international leaders in substance use research and education. Given AMERSA’s strong track record in excellent, evidence-based conference training, the potential of this application for strengthening interdisciplinary substance use research, training, practice, and policy is substantial.